GROWTH, PUBERTY &DISORDERS--PHYSIOLOGY, PATHOPHYSIOLOGY &MOLECULAR BIOLOGY

The objective of this project is to advance understanding of the mechanisms that underlie normal and abnormal puberty, and to apply this knowledge to improve existing therapy for disorders of puberty. Since somatic growth is a major determinant of the timing of pubertal onset, a further objective is to clarify the mechanisms of normal growth and of growth failure. Principle areas of laboratory investigation include the mechanisms of normal growth and puberty. Principle areas of clinical investigation include the mechanism of the gonadotropin-independent forms of precocious puberty, the developmental changes in hypothalamic regulation of gonadotropin secretion, the behavioral changes associated with normal and abnormal pubertal development, the mechanisms of prepubertal and pubertal growth, the role of pubertal sex steroids in the acquisition of normal adult bone density, the treatment of central precocious puberty with an analog of luteinizing hormone-releasing hormone (LHRH), the treatment of familial male isosexual precocious puberty with combined antiandrogen and aromatase inhibitor, the evaluation of new approaches to the diagnosis of growth hormone deficiency and to the differential diagnosis of delayed puberty, the treatment with synthetic parathyroid hormone of children with hypoparathyroidism, the treatment with growth hormone of children with Turner syndrome and with non-growth hormone-deficient short stature, and the treatment with insulin-like growth factor-1 of children with growth hormone insensitivity and of children with non-growth hormone-deficient short stature. This protocol has been terminated because principal investigator has left NIH. Project will transfer to Penelope Feuillan, M.D. as principal investigator subsequent to Dr. Cutler's departure.